Core--Vector Core

The Vector Core is a critical resource to members of the Institute for Human Gene Therapy providing access to a wide array of gene transfer technology. This dedicated facility is run by Dr. Guang-ping Gao, who has extensive academic based experience in recombinant viruses. The Core has assembled a comprehensive inventory of plasmids, cell lines, and viruses useful to the development of vectors. More comprehensive service is provided in the design, creation, production, and analysis of recombinant viruses. A number of vector systems are available through the Core, including murine-based retroviruses, adenoviruses, and adeno-associated viruses (AAV). The Vector Core maintains strong links to key laboratories in the Institute for Human Gone Therapy involved in novel vector development. Relevant innovations are quickly brought into the Vector Core, where they are validated and distributed to faculty. In the context of this P01, the Vector Core will play an important role. Methodology for creating chimpanzee adenoviruses will be developed in Project 1 and transferred to the Core who will provide services in terms of vector creation and expansion for all four projects.